Cardiometabolic Consequences of the Loss of Ovarian Function

PROJECT SUMMARY/ABSTRACT
Menopause accelerates cardiovascular disease (CVD) risk due to changes in the hormone environment and
adverse changes in cardiometabolic function. The overarching objective of the Colorado SCORE is to
advance scientific knowledge of the impact of gonadal aging on the regulation of bioenergetics,
abdominal adiposity and cardiometabolic function. We have shown that age-associated vascular
endothelial dysfunction, a key antecedent for the development of CVD, is accelerated with gonadal aging in
women. We also demonstrated that the menopausal-related decline in estradiol (E2) triggers the development
of oxidative stress-mediated endothelial dysfunction. Endothelial function, measured by brachial artery flow-
mediated dilation (FMD) decreased with short-term ovarian suppression (via gonadotropin releasing hormone
antagonist, GnRHANT) in premenopausal women and this was reversed with E2 add-back. Prior SCORE
research demonstrated that long-term ovarian suppression results in a marked increase in abdominal
adiposity, particularly visceral, that is prevented by E2. How these adverse changes in adiposity influence
vascular aging with E2 deficiency is unknown. Additionally, the mechanisms underlying the increased adiposity
and impaired endothelial function in response to the withdrawal of E2 are not completely understood. Emerging
evidence links the tryptophan-kynurenine (TRP-KYN) pathway to the regulation of vascular function,
adiposity, and the aging process. Our preliminary data in men suggest that increased plasma KYN is
associated with increased adiposity and endothelial dysfunction in older men with low testosterone. It is
unknown if E2 regulates the TRP-KYN pathway in vascular and adipose tissues. Accordingly, Aim 1 will
investigate the impact of increased abdominal visceral adiposity superimposed on the effects of E2
withdrawal on endothelial function. FMD and visceral fat area will be assessed before and after ovarian
suppression with randomization to either E2 or placebo add-back. In collaboration with Projects 2 and 3, Aim 2
will determine if tissue-specific alterations in the TRP-KYN pathway are mechanistically linked to
increased adiposity and endothelial dysfunction with E2 withdrawal. TRP-KYN metabolites and key
enzymes in the pathway will be measured in blood, peripheral vascular endothelial cells, adipose tissue and
isolated adipocytes acquired before and after the intervention. In collaboration with Projects 2 and 3, an
Exploratory Aim will further examine the mechanistic role of TRP-KYN metabolism with E2 suppression on
endothelial function using an ex vivo serum exposure cell culture model and by conducting vasodilation
studies of arteries from animals in projects 2 and 3 with varying E2 status. Collectively, Project 1 will provide
unique mechanistic insight by which acute and more chronic loss of ovarian function contributes to increased
adiposity and endothelial dysfunction and will identify novel therapeutic targets to attenuate/prevent
menopause-related cardiometabolic dysfunction and reduce the risk of CVD.

Public health relevance
PROJECT NARRATIVE Menopause increases cardiovascular disease risk due to changes in the hormone environment and adverse changes in cardiometabolic function. The research findings should provide new information on the impact of increased abdominal adiposity on vascular function with estrogen deficiency. These findings may lead to the development of novel therapeutic targets to prevent menopause-related cardiometabolic dysfunction and reduce the risk for cardiovascular disease.